Genetics of the Neuromuscular Junction: Mechanisms and Disease Models

DESCRIPTION (provided by applicant): The goal of this proposal is to understand how dominant mutations in tRNA synthetase genes cause axonal degeneration in the peripheral nervous system. Mutations in glycyl tRNA synthetase (GARS) and tyrosyl tRNA synthetase (YARS) cause Charcot-Marie-Tooth type D and Dominant Intermediate Charcot-Marie- Tooth type C (CMT2D and DI-CMTC) respectively. These enzymes are well characterized for their function in charging amino acids onto their cognate tRNAs for translation. However, there are few correlations between the effects of these mutations on this activity and the disease phenotypes. We have demonstrated this using a mouse model of CMT2D, in which an amino acid substitution in GARS causes a dominant peripheral neuropathy despite normal enzymatic activity of the mutant protein, whereas a loss-of-function allele that eliminates Gars expression does not cause a dominant phenotype despite lower overall levels of enzyme activity. These results lead us to hypothesize that mutant forms of GARS cause disease either through the loss of an unknown, noncanonical function, or through a pathological gain-of-function. We therefore propose three aims to better understand the disease mechanisms of CMT2D and DI-CMTC. In Aim 1, we will create a mouse model of DI-CMTC using a Conditional knockin strategy to introduce human disease alleles into the mouse Yars gene. Preliminary studies indicate that decreasing Yars expression to 35% of wild type levels does not cause a peripheral neuropathy, suggesting that like Gars, a mutant form of the YARS protein is required to cause disease. The Yars conditional knockin mice will allow us to further explore whether GARS and YARS mutations do indeed share a common pathogenic mechanism. In Aim 2, we will test a proposed disease mechanism based on in vitro and biochemical data from our collaborators, Drs. Schimmel and Yang. This model proposes that altered interaction between GARS and DAXX, a protein implicated in other motor neuron disease pathways, may underlie CMT2D. We will test this in vivo by again using a conditional knockin strategy to target residues in GARS that are essential for the DAXX interaction. If the proposed mechanism is correct, this should cause a severe neuropathy phenotype. In Aim 3, we will combine mouse and human genetics to understand the genetic basis for the variable severity of CMT2D. CMT2D patients may present with purely motor deficits (diagnosed as distal Spinal Muscular Atrophy type V, dSMAV), whereas others carrying the same mutation present with both motor and sensory deficits. We are able to reproduce this variability in mice and have mapped a locus on Chr. 1 that contributes to the preservation of sensory axons. We will use mouse genetics to identify the modifying gene on Chr. 1. We will also determine if the same region of the human genome contributes to variable severity in CMT2D patients in collaboration with Dr. Albena Jordanova. The identification of modifier loci will improve our understanding of CMT2D mechanisms, suggest therapeutic strategies, and enhance diagnosis/prognosis of CMT2D patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal seeks to combine research in mouse models of hereditary diseases of the peripheral nervous system (Charcot-Marie-Tooth Disease) with research in human genetics to better understand disease mechanisms and to suggest new therapeutic strategies. This work will lead to improved genetic diagnoses in humans, create directly relevant animal models for preclinical testing of therapies, and identify new therapeutic targets for these diseases, and possibly other motor neuron diseases such as Amyotrophic Lateral Sclerosis (ALS). Relevance to Public Health: This proposal seeks to combine research in mouse models of hereditary diseases of the peripheral nervous system (Charcot-Marie-Tooth Disease) with research in human genetics to better understand disease mechanisms and to suggest new therapeutic strategies. This work will lead to improved genetic diagnoses in humans, create directly relevant animal models for preclinical testing of therapies, and identify new therapeutic targets for these diseases, and possibly other motor neuron diseases such as Amyotrophic Lateral Sclerosis (ALS). __SpecificAimsTextDelimiter__ Specific Aims: The goal of this proposal is to understand how dominant mutations in tRNA synthetase genes lead to peripheral neuropathies. In humans, mutations in glycyl tRNA synthetase (GARS) and tyrosyl tRNA synthetase (YARS) lead to Charcot-Marie-Tooth type 2D (CMT2D) and Dominant Intermediate Charcot-Marie- Tooth type C (DI-CMTC) respectively (2, 4). These are degenerative diseases that specifically affect the peripheral nervous system, causing axonopathy and denervation that is most severe in the distal limbs. The known function of these ubiquitously expressed enzymes is to charge amino acids onto their cognate tRNAs for translation. All of the mutations that cause CMT2D or DI-CMTC are amino acid substitutions, and there is no correlation with their impact on tRNA charging activity and the disease phenotype. Studies in mouse models of Gars and Yars clearly establish that loss-of-function alleles that decrease expression at the mRNA level without producing a mutant protein product do not cause a dominant phenotype, whereas dominant point mutations in Gars cause a CMT2D-like peripheral neuropathy in mice (5). These studies have led us to conclude that the dominant mutations in GARS and YARS lead to either a novel pathological function or are impairing an unknown, non-canonical function of these enzymes. While there are many genes associated with different forms of Charcot-Marie-Tooth disease (CMTs), it is particularly challenging and intriguing to explain how the GARS and YARS mutations cause disease, and while it is inviting to assume that these related enzymes are causing related diseases through shared mechanisms, this remains to be determined. These mutations are in many ways analogous to other neurological diseases involving "Housekeeping" genes, such as SOD1 or SMN1 in Amyotrophic Lateral Sclerosis (ALS) or Spinal Muscular Atrophy (SMA), respectively. We therefore propose the following three aims, using mouse genetic models and correlates in the human genome, to better understand the pathophysiology and mechanisms underlying GARS and YARS mutations and peripheral neuropathy. Aim 1) We will create mouse models of DI-CMTC to understand the cell autonomy and pathophysiology of Yars mutations. DI-CMTC patients have both axonal degeneration and demyelination, resulting in denervation and nerve conduction velocities that are reduced to "Intermediate" levels. Whether the demyelination is secondary to the axonal dystrophy is an outstanding question. Mutations in mice that reduce Yars expression at the RNA level do not cause a dominant neuropathy, suggesting that expression of mutant forms of the YARS protein is necessary to cause disease. We will therefore introduce human disease alleles into the mouse Yars gene using a "Conditional Knockin" strategy. This approach will allow us to control the timing and expression pattern of the mutant protein (Schwann cells versus neurons for example) to determine the factors influencing disease severity and progression. A comparison of these mice to Gars-CMT2D models will also allow us to begin to determine if these mutations act through common mechanisms. Aim 2) We will test the novel hypothesis that Gars mutations cause peripheral neuropathy by altering a NEDD8-dependent interaction of GARS with DAXX. Data from our collaborators, Drs. Schimmel and Yang, indicate that GARS is post-translationally modified by NEDD8 addition (neddylation), allowing an interaction with DAXX, a protein that has been implicated in motor neuron-specific disease pathways. We will use existing and new mouse models to test the extensive body of in vitro and biochemical evidence supporting this noncanonical function of GARS to determine its in vivo relevance to CMT2D. Our anticipation is that eliminating the GARS-DAXX interaction will create a severe disease allele. We will therefore target the amino acids necessary for the neddylation of GARS to see if they cause a dominant neuropathy phenotype in mice. We will also breed the existing Gars mutant mice to Daxx dominant-negative transgenic mice to test the importance of this pathway in CMT2D. Aim 3) We will determine the genetic basis for the variable phenotype of Gars mutations in mice and humans. Patients with mutations in GARS may present with a purely motor neuropathy (diagnosed as distal Spinal Muscular Atrophy type V, dSMA-V), a motor and sensory neuropathy (CMT2D), or in some cases are asymptomatic. These different presentations represent varying disease severity, and one form does not progress to another with time (6). We are able to reproduce this variable severity in mice by altering the genetic background, and have mapped loci in the mouse genome that correlate with the almost complete preservation of sensory axons in peripheral nerves of Gars mutant mice. We will continue studies in the mouse to identify the genes responsible for this change in phenotype, and, through a collaboration with Dr. Albena Jordanova at the University of Antwerp, we will determine if the syntenic regions of the human genome have a similar effect. Identification of these modifier loci will give additional insights into disease mechanisms, suggest therapies, and provide improved diagnostic/prognostic testing for CMT2D patients.